Exploring Drugs Targeting Hippo Pathway

Project Summary/Abstract
Per the NCI Diversity Supplement Guidelines, this section is not required. The research supplement
proposal does not change the activities of the Parent Award.

Public health relevance
Project Narrative Per the NCI Diversity Supplement Guidelines, this section is not required. The research supplement proposal does not change the activities of the Parent Award.